Conduct of studies to evaluate the toxic and carcinogenic potential of naturally occurring asbestos in laboratory animals for the National Toxicology Program (NTP)

The goal of this project is to develop inhalation exposure and tissue burden preparation and analysis methods to facilitate the NTPs designing of toxicity and carcinogenicity studies of naturally occurring asbestos. There is a need to generate high quality, dose response data on different types of asbestos fibers. However, there are numerous methodological challenges that need to be resolved prior to finalization of the design of these studies. Method development work is currently in progress. Keywords: toxicity, carcinogenicity, asbestos, inhalation, fiber